Evaluation of growth potential of ice-free vitrified heart valves in a pediatric porcine model.

Abstract: Heart valve replacement in children is a serious problem because there are no heart valve implants
that grow with the patient. The valves that are currently employed need to be changed as the patient grows
with a very high associated mortality rate (~40%). In response to this clinical need, we are pioneering an
entirely new approach to deliver growing heart valve implants, which we are calling partial heart transplantation
(PHT). PHT differs from heart transplantation because only the part of the heart containing a valve is
transplanted. Based on our preliminary data in immunosuppressed piglets, we recently performed the world’s
first human partial heart transplant on 4/22/2022 with demonstrated valve growth. However, the chance of a
donor partial heart transplant being available at just the right time is low. Therefore, we propose development
of a network of tissue banks with technology licenses at major pediatric cardiovascular medical centers
nationwide in preparation for clinical application. Our central hypothesis is that vitrified and nanowarmed PHTs
can fulfill both their hemodynamic and biological functions after orthotopic transplantation in growing children.
In this Phase I proposal there are three specific aims: First we propose optimization of short-term preservation
protocols. Our working hypothesis for this aim is that PHTs will tolerate longer post-mortem cold ischemic
times than intact hearts. The impact of procurement and refrigeration on piglet-derived PHTs will be evaluated
by assessment of viability in vitro. This will establish the anticipated geographic range for PHT procurement
after dissection based upon estimated refrigerated travel time. In the second specific aim we will optimize
vitrification protocols for PHTs. Our working hypothesis for this aim is that ice-free cryo-preservation employing
tissue vitrification, rapid nanowarming and apoptosis inhibition developed for adult porcine pulmonary heart
valves can be further optimized for smaller PHTs required for pediatric cases. Different cryoprotectant loading
times, exposure conditions, and apoptosis inhibitors will be evaluated by assessment of viability in vitro. This
will establish the optimal vitrification protocol for pediatric PHTs. In the final aim we will evaluate post-
transplant growth, leaflet viability and hemodynamic function of optimally vitrified and nanowarmed
cryopreserved PHTs. Our working hypothesis for this aim is that optimized protocols will allow vitrified PHTs
that were banked for one month to function in vivo like fresh PHTs. The optimized protocols developed in the
earlier aims will be evaluated in a swine leukocyte antigen matched growing immunosuppressed piglet PHT
model by transplantation. This will establish the PHT vitrification, warming, and banking methods for future
clinical application.

Public health relevance
Narrative: Congenital heart defects cause over 180,000 neonatal and infant deaths per year world-wide. Many of these deaths are caused by heart valve dysfunction and the poor treatment options available. We propose development of living partial heart transplants that can be banked after ice-free vitrification and nanowarmed rapidly from cryogenic storage temperatures to avoid risks of ice-induced tissue damage. Commercialization will be by development of a network of tissue banks with HLA and blood group antigen typed tissues available for matching with patients upon demand.